Texas NeuroAIDS Research Center

Abstract
This application is for supplemental bridge funding to maintain operation of the Texas NeuroAIDS
Research Center (TNRC) for a brief period of time (U24MH10093010). This project recruits HIV positive
patients, characterizes them medically and neuropsychologically, performs autopsies when
appropriate, maintains a human specimen repository, and distributes specimens worldwide. The
funding for fiscal year 5 of this cooperative agreement U24 was to end on February 28, 2023. As of this
writing the program is operating on a no cost extension combined with a pending request for “carry
forward” funds from prior years that has not yet been approved. The application for continued funding
via contracting is under a review by the NIH. According to federal officials the decision regarding funding
in the future will not be known for approximately six months from the end of the U24. That has created
a “funding gap.” Following the advice of federal officials, we are applying for supplemental bridge
funding to maintain normal operations until a decision on long term funds is issued by the NIH. We
were advised to apply for funds that will allow operation through August 31, 2023, which amounts to
roughly six months of normal operation from the time the U24 was to end. Our request for bridge funds
for that period is calculated in a manner suggested by the NIH. We have subtracted from our request
two sources of potentially available funds: 1) the balance that was available for an approved no cost
extension, and 2) a separate amount corresponding to a pending request for carry forward of unspent
funds from prior years. Assuming that these two requests are both approved and enacted by the NIH,
we calculated an amount of additional funds necessary to operate through September 1, 2023. That
amount is reflected in our budget request and its justification. Supplemental funding is requested to
maintain operation until the long-term plan for funding the project become clear.

Public health relevance
Project narrative The Texas NeuroAIDS Research Center (TNRC) is one of four clinical sites of the National NeuroAIDS Tissue Consortium (NNTC). The research strategy of the NNTC is to clinically characterize HIV infected patients, collect and bank clinic specimens, curate clinical data, perform autopsies, maintain a human specimen repository, and provide human specimens to researchers worldwide, including especially those doing research on HIV in the nervous system. We are a steady resource for the HIV/AIDS research community primarily, with added service to various overlapping human medical groups including especially elderly populations, substance abuse populations, and populations of economically and socially disadvantaged people.